2/2 Bangladesh Center for Global Environmental and Occupational Health-US

ABSTRACT:
This is the renewal U2R application for the “Bangladesh Center for Global Environmental and Occupational
Health (GEOHealth)”- awarded along with the linked U01 grant in 2015 to the University of Chicago (UofC) and
International Centre for Diarrheal Disease Research, Bangladesh (ICDDR,B). The project will be implemented
in close collaboration with the Bangabandhu Sheikh Mujib Medical University (BSMMU) and selected US as well
as local academic institutions to continue and augment complementary training expertise relevant to this
proposal. The goal of the Bangladesh GEOHealth Center was to strengthen the research capacity of Bangladesh
on pressing environmental and occupational health threats. During the current funding period, the Bangladesh
GEOHealth Center has positively impacted on the foundation of environmental health research capacity in
Bangladesh by training more than 200 students, young and mid-career researchers from diverse background
through custom-designed in-country 2-day workshops and 2-week short-courses, and 16 fellows through US-
based postdoctoral fellowships and 12-week (one academic quarter) training at the UofC. Evaluation of short
courses and workshops in Bangladesh indicated increased knowledge and high satisfaction of the participants.
The 16 fellows who received training at UofC have demonstrated outstanding research productivity in term of
publications, presentations, grants, and career development. They produced 90 peer-reviewed publications
during and after the training period. All 16 US-based fellows reported that they had cooperative and influential,
mentor(s) during the training period and the trainees continued to receive guidance from the mentor(s) even after
completion of the training. Despite these demonstrable impacts there remains a critical need for additional
research capacity in Bangladesh to address the country’s huge environmental and occupational health burden
given the acute shortage of researchers trained in modern environmental health research methods, especially
data science and mHealth tools and techniques. In this renewal application, we propose to continue and augment
our Bangladesh and US- based training activities through i. Workshops (2 day), ii. Short courses (1-2 week) iii.
One academic quarter course work at UofC, iv. A master’s degree program (1-year) at UofC, and v. Postdoctoral
training (1-year) at UofC. We will refine the training curricula that we used over the past 5 years to incorporate
more materials on utilizing advanced technologies and analytical tools (artificial intelligence/machine learning
(AI/ML), image analysis, mobile health (mHealth) data capture/analytics, exposure data science, etc.) for
analyzing environmental health data with the existing materials, all of which will incorporate the linked U01
application’s research focus. A rigorous evaluation system will help the Administrative and External Oversight
Committee to monitor and ensure program success. We have successfully implemented the current phase of
the training grant, and we believe that our renewal training program will address critical gaps in environmental
and occupational health research capacity, and bring benefit to a wide variety of researchers in Bangladesh.

Public health relevance
PROJECT NARRATIVE: GEOHealth Bangladesh Center for research training main phase grant was jointly awarded to the University of Chicago (UofC) and International Centre for Diarrheal Disease Research, Bangladesh (ICDDR,B) in 2015 to strengthen the research capacity of Bangladesh on pressing environmental and occupational health threats. In this renewal phase, we propose to refine and advance the training curricula that were used over the past 5 years to incorporate more materials on utilizing advanced technologies and analytical tools (artificial intelligence/machine learning (AI/ML), image analysis, mobile health (mHealth) data capture/analytics, exposure data science, etc.) for analyzing environmental exposure and health effects data with the existing materials, all of which are highly relevant to the linked U01 application’s research. Moreover, we propose to leverage the newly launched Masters of Public Health (MPH) and Masters of Science in Precision Health (MSPH) degree programs at UofC as a long-term training option, along with the 1-year post-doctoral and 12-week training at UofC, and shorter-term in-country short-courses (2 weeks) and workshops (1-2 days) in Bangladesh.